Facilitating sustainable partnerships for STEM education and accessible pathways for STEM students using an evidence-based model

Abstract
The fields of science, technology, engineering, and mathematics (STEM), are deeply impacted by systemic
educational inequities in the U.S. public school system, creating barriers to science, often among racial minorities
and individuals from underserved communities. Results of our recent work suggests that some of these barriers can
be mitigated through weekly STEM enrichment activities in underserved high school classrooms, facilitated by a
team of near-peer mentors (NPMs) from the same or nearby communities; high school students gain more positive
attitudes toward science and scientists, increased content knowledge, and increased understanding of the relevance
of science in their lives by the conclusion of the program. Our objectives in this proposal are to disseminate
sustainable, refined NPM-led science enrichment programs with enhanced in-classroom and virtual mentoring
in underserved classrooms through partnerships within our home state, and to further investigate shifts in
participants’ attitudes toward science. In pursuing these objectives, we aim to: (1) Determine whether enhanced
in-classroom mentoring, paired with virtual mentoring can be used as effective strategies to engage underserved
students; (2) Elucidate the underlying mechanism(s) for students’ attitudinal changes towards science with near-
peer mentoring; and (3) Evaluate effective strategies for the dissemination and the sustainability of NPM programs.
We will partner with minority-serving universities in Maryland, and local high schools in their communities to
disseminate the NPM model. We hypothesize that dissemination of this enhanced NPM model will lead to a network
of sustainable programs that will promote shifts in students’ classroom performance, attitudes, engagement, and
growth mindsets. Our expertise puts us in a unique position to train others in implementation of this model, thus
increasing the number of under-represented students who have access to meaningful and preparatory experiences
in STEM. We will use a matched comparison group design to evaluate the efficacy of the near-peer mentorship
programs for students, and fidelity surveys to evaluate the consistency of program implementation across sites. The
dissemination of a sustainable NPM model will help us accomplish our long-term goal of addressing systemic
educational inequities, and increase our capacity for recruitment of students from underserved and underrepresented
backgrounds into STEM internships, providing an element of continuity for participants. The proposed work will
also provide a blueprint for other SEPA programs to disseminate evidence-based outreach programs.

Public health relevance
Project Narrative The fields of science, technology, engineering, and mathematics (STEM), are deeply impacted by educational disparities and inequities in the US public school. Our objective in this proposal is to disseminate sustainable near-peer mentor-led science enrichment programs within underserved high school classrooms through university partnerships. The proposed work will help establish the near-peer mentor model as a way to address systemic inequities in STEM education and increase the capacity for recruitment of students from underrepresented backgrounds into STEM internships at our and partnering institutions.